Systems Approaches to Novel Molecular Mechanism in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Recent FDA approval of the anti-beta-amyloid (Ab) antibodies Aducanumab and Lecanemab as the first
mechanism-based Alzheimer's disease (AD) therapies has strengthened the central role of the Ab protein in AD
pathogenesis. However, these imperfect medications have only shown modest cognitive benefits, as AD clinical
symptoms often occur decades after amyloid formation and deposition, and the molecular mechanisms leading
to the demise of neurons in AD brains remain poorly understood. Nevertheless, the success of anti-Aβ
therapeutic antibodies and identification of an APP mutation that protects against AD attest to the existence of
amyloid-related molecular mechanisms that restrain Ab toxicity and confer resilience to AD. Meanwhile, cryo-
electron microscopy structural studies have revealed several types of Aβ filaments isolated from AD brains, and
they differ from those assembled in vitro. These observations suggest that in vivo assembly of amyloid filaments
may require additional cellular factors that control progression of amyloid pathology and connect with non-
amyloid AD pathways. Proteomic studies identified three prominent groups of AD pathology-associated proteins
(ADPs). The current project seeks to test the hypothesis that Midkine and Netrin proteins, top-ranked human
ADPs regulate Ab pathology and connect non-amyloid pathways in AD protein networks. The choice of Midkine
and Netrin was informed by unbiased proteomic screening of hundreds of human brains, by validation studies
that establish functional and physical links to amyloid pathology, and by their potential connections to UNC5C
and ApoE/LRP pathways. The project is organized into three specific aims: 1) to determine the
pathophysiological roles and AD protein networks mediated by Midkine and Pleiotrophin; 2) to map Midkine
interactome and its physical interactions with Aβ filaments; 3) to elucidate the synergistic roles of Midkine,
Pleiotrophin, and Netrin-1 in AD pathogenesis. These studies will reveal the impact of select AD pathology-
associated proteins on disease progression, uncover non-amyloid pathways mediated by these ADPs, and
elucidate the biochemical mechanisms by which Midkine and Netrin family ADPs regulate assembly of Ab
filaments to potentially confer resilience to amyloid toxicity. Success of this project will inform the development
of more robust experimental models and more specific and sensitive therapeutic and imaging agents for AD.

Public health relevance
PROJECT NARRATIVE This research project aims to understand the molecular mechanisms leading to the demise of neurons in Alzheimer's disease (AD) brains and identify potential therapeutic targets and biomarkers. By studying select AD pathology-associated proteins and their impact on disease progression, non-amyloid pathways mediated by these proteins, and the biochemical mechanisms by which they regulate assembly of Aβ filaments, this project seeks to inform the development of more effective experimental models and therapeutic and imaging agents for AD. The ultimate goal is to enhance public health by improving our fundamental knowledge of AD pathogenesis and finding new ways to lengthen life, reduce illness, and minimize disability caused by this devastating disease.